Targeting ER stress response in B-cell chronic lymphocytic leukemia

Project Summary/Abstract
Chronic lymphocytic leukemia (CLL) is an incurable B cell malignancy that represents 30% of all adult
leukemia. Although the initiating events are unclear, exposure to factors such as bacterial polysaccharides,
lipoproteins, and DNA has been proposed to drive proliferation in CLL, via binding to the B cell receptor (BCR).
These factors also serve as ligands for Toll-like receptors (TLRs), a class of receptors critical for innate
immunity and that play multiple roles in B cell differentiation and activation. However, exactly how TLR ligands
are involved in CLL is unclear, as some studies observe apoptosis after treatment of CLL cells with TLR
ligands and other studies observe proliferation. Understanding which ligands have which effects is particularly
crucial at present, as TLR ligands are proposed as immunomodulatory agents to coach our immune system to
combat CLL. As a clinical case in point, ibrutinib is used to inhibit the BCR signaling that drives proliferation of
CLL; but approximately 60% of CLL patients treated with ibrutinib at the Moffitt Cancer Center dropped out of
the therapy due to toxicity. In addition, CLL undergoes Richter's transformation into fast-growing diffuse large B
cell lymphoma in increasing numbers of patients receiving ibrutinib therapy. Hence, halting B cell proliferation
in CLL remains a challenge. Our group used our in-depth understanding of the endoplasmic reticulum (ER)
signaling to consider this problem from a different angle, finding that for CLL cells to survive they require
activation of the ER stress response. We also found that the IRE-1/XBP-1 pathway of the ER stress response
is activated by TLR ligands, to promote proliferation of CLL cells in vitro. These results led us to hypothesize
that in CLL cells, specific TLR ligands activate the IRE-1/XBP-1 pathway through TLR and BCR signaling, to
promote malignant progression of CLL. We have generated a novel mouse model in which the XBP-1 gene is
knocked out specifically in B cells in Eµ-TCL1 (CLL) mice, and showed that BCR signaling is downregulated in
XBP-1-deficient Eµ-TCL1 B cells. In addition, we have developed a specific and potent inhibitor of the IRE-
1/XBP-1 pathway, B-I09, which induces apoptosis of CLL in vivo and does not exhibit overt toxicity in mice.
Treatment with B-I09 also reduced BCR signaling in Eµ-TCL1 B cells. Using these novel tools, we will
determine exactly which TLR ligands promote malignant progression of CLL in vivo via activation of the IRE-
1/XBP-1 pathway and BCR signaling, and whether targeting the IRE-1/XBP-1 pathway can thwart the two-
pronged effect of TLR ligands. Based on our new data, we also propose to test whether CLL cells lacking XBP-
1s may activate regulated IRE-1-dependent decay (RIDD) to counter apoptosis. These goals are summarized
in the following specific aims. Aim 1: Establish that TLR ligand-induced activation of the ER stress response
supports malignant progression of CLL in vivo, and proliferation and survival of human CLL cells. Aim 2:
Investigate whether targeting XBP-1 decelerates TLR ligand-induced progression of CLL by suppressing BCR
signaling. Aim 3: Investigate how RIDD contributes to the progression of CLL in XBP-1KO/Eµ-TCL1 mice.

Public health relevance
Project Narrative Chronic lymphocytic leukemia (CLL) is still an incurable B cell cancer, and CLL cells respond to bacterial or viral products, called TLR ligands. Although some TLR ligands were shown capable of coaching our immune system to combat cancer, we showed that some TLR ligands can activate the endoplasmic reticulum (ER) stress response pathway to support the growth of CLL cells. Here we will find out which TLR ligands can activate the ER stress response in CLL and will test whether targeting the ER stress response pathways can halt TLR-induced CLL proliferation.